Wisconsin Nathan Shock Center

Abstract Energetics of Longevity Core
The Wisconsin Nathan Shock Center (WiNSC) will build upon the remarkable strengths of the University of
Wisconsin-Madison (UW-Madison) to provide state-of-the-art resources, infrastructure, and expertise in the basic
biology of aging. It has recently become clear that metabolism is of central importance in the biology of aging,
with both diet composition and timing, as well as key molecular sensors of nutrient availability, having profound
effects on healthy aging and lifespan.
The Energetics of Longevity Core will serve as a central hub for both novel and existing services to which
WiNSC members, Research Award grant recipients, and the national aging community will have access. The
innovative platforms established as part of this core includes 1) a Metabolite Tracer platform, which in
collaboration with the Discovery and Integration Core D will enable molecule-level tracing of metabolites as they
move through the cells and bodies of rodents of different ages subjected to different dietary, genetic, and
pharmaceutical interventions; and 2) a Genetics Toolkit which will provide resources and training to help
geroscientists leverage the growing datasets from aging studies conducted in genetically diverse mice.
Integration with the Translation and Application Core E will support the Liquid Biopsy platform in generating
multiple species panels for translation and reverse translation studies. Finally, we will establish and guide users
through existing UW-Madison resources that are relevant to WiNSC’s mission, including the Mouse Phenotyping
and Surgery Service, Advanced Genome Editing Lab, Animal Models Core, Small Animal Imaging and
Radiotherapy Facility, Behavior Testing Service, Flow Cytometry Laboratory, Translational Research Initiatives
in Pathology Laboratory, Comparative Pathology Laboratory, and the Optical Imaging Core. Access to services
will be fee-based and tailored for studies that are aligned with the mission and vision of the Center. The efforts
of the Energetics of Longevity Core are integrated with those of the other WiNSC Cores and affiliated services
and are led by an internationally-recognized leadership team with expertise in aging, metabolism, genetics, and
fluxomics, particularly as applied to rodent studies. This Core will enable the expansion of metabolism of aging
research, including mechanistic studies that uncover how aging and metabolism intersect. We will work with the
RD Core to support innovative Pilot and Idea Award projects as well as fee-for-service use to support
investigator-initiated projects relevant to the biology and metabolism of aging.

Public health relevance
Project Narrative Not required per RFA-AG-25-012.